Discovery, Mechanism and Function of Type-V CRISPR-Cas Inhibitors

PROJECT SUMMARY We report no changes from the parent award.

Public health relevance
PROJECT NARRATIVE We report no changes from the parent award.